Examining Effort-Based Reward Processing and Lifetime Stress in Relation to Depression during Adolescence

PROJECT SUMMARY/ABSTRACT
Adolescence is a developmental period characterized by increased reward responsivity; it also reflects a high-
risk period for the emergence of depression. Adolescence represents an ideal time to identify risk factors and
refine the specificity of models of the development and pathophysiology of depression. Most research elucidating
the role of reward processing during development and depression has studied reward liking, as indexed by the
reward positivity (RewP) event-related brain potential (ERP); however, previous work indicates that reward
processing may be better conceptualized in terms of multiple aspects beyond liking, including wanting—a
process also impaired in depression. Using a novel effort-reward task developed by our group, the primary goal
the research is to determine the impact of effort expenditure on multiple reward processing stages (i.e., effort-
based reward processing) using several ERPs in a well-characterized adolescent sample. In the proposed study,
150 adolescents (aged 14 to 17) and their caregivers from the greater Tallahassee, FL community will complete
self-report questionnaires and clinical interviews as part of three-year follow-up visit of an ongoing longitudinal
study. Adolescents will complete the effort-doors task to elicit ERPs linked to multiple reward processing stages:
effort complete, reward anticipation, and sensitivity to reward receipt. Consistent with developmental research,
we predict age to be associated with a larger impact of effort on multiple stages of reward processing, such that
older adolescents will exhibit larger ERPs across multiple stages of reward processing following high effort (Aim
1). In terms of depression, we predict that increased depressive symptoms will relate to blunted effort-based
reward processing, such that the impact of effort on multiple reward processing stages will be potentiated among
adolescents with increased depressive symptoms (Aim 2). A secondary goal of this research is to elucidate
diathesis-stress models in relation to depression. The proposed study will also examine whether lifetime stress
exposure, as measured using the Adolescent Stress and Adversity Inventory, impacts ERPs linked to specific or
multiple stages of reward processing–and whether lifetime stress exposure interacts with specific reward
processing stages to explain emerging symptoms of depression. We predict that lifetime stress exposure will
potentiate the impact of effort on reward processing following high effort completion (Aim 3). We also predict that
increased lifetime stress exposure will interact with deficits in multiple stages of reward processing to explain
increased depressive symptoms among adolescents (Aim 4). The proposed study will provide expertise in
developmental psychopathology, broaden knowledge of multiple reward-related processes and their
measurement, and provide training in clinical interviewing and life stress assessment in the context of emerging
depression. This fellowship has the potential to identify multiple reward-related deficits and increased lifetime
stress exposure as factors related to emerging depression that elucidate the etiopathogenesis of depression—
and establish novel targets that can be studied in intervention and prevention strategies in future research.

Public health relevance
PROJECT NARRATIVE Adolescence is a high-risk period for increased depression, and increased depression is associated with a variety of adverse outcomes, including academic difficulties, increased physical health problems, increased suicidality, and poor social and occupational functioning that often persist well into adulthood. Given this substantial burden, it is critical to improve our understanding of risk factors for depression, including blunted reward processing and increased lifetime stress exposure and determine the extent to which they contribute to the etiopathophysiology of depression during adolescence. The proposed project will test whether event-related potentials (ERPs) linked to multiple stages of reward processing are associated with (1) chronological age, (2) adolescent depressive symptoms, and (3) lifetime stress exposure; further, the proposed project will examine (4) whether lifetime stress exposure interacts with multiple stages of reward processing to explain depression among 150 adolescent boys and girls aged 14 to 17.